Mechanistic studies of enzymes in isoprenoid biosynthesis

DESCRIPTION (provided by applicant): All isoprenoids are constructed by isopentenyl diphosphate (IPP) and its isomer dimethylallyl diphosphate (DMAPP). The essential role played by the deoxyxylulose phosphate (DXP) pathway in prokaryotic IPP and DMAPP biosynthesis and the lack of this pathway in animals makes the DXP pathway enzymes ideal candidates for developing broad-spectrum antibiotics. The DXP pathway is also targeted for herbicide development because its plant mutants are not able to synthesize sufficient amounts of carotenoids and chlorophylls for normal growth. The low natural abundance of isoprenoids has also stimulated interest in their production through bioengineering. Because the limiting factor in bioengineering-based isoprenoid production is the inadequate supply of IPP and DMAPP, mechanistic studies of the DXP pathway will guide the construction of host strains for bioengineering-based isoprenoid production. The proposed project will study the reaction mechanism of one of the DXP pathway rate-limiting steps, a reductive dehydration reaction catalyzed by an iron-sulfur cluster containing IspH protein. Several major achievements accomplished in preliminary studies serve as the basis for the proposed work. In the preliminary studies, IspH activity was improved by 97-fold relative to that reported in the literature. In addition, using substrate analogs, several IspH mechanistic options were examined and narrowed down to a model that is consistent with all current data. [57Fe]-labeled IspH was isolated in large quantities (~500 mg from a one-day purification). Initial EPR and Mvssbauer characterizations demonstrated that the IspH protein developed has both a high degree of iron- sulfur cluster load and homogeneity. Based on these achievements, the team has acquired all the necessary materials and protocols for conducting the proposed studies. Specifically: In Aim 1, both enzyme- and substrate-based intermediates will be trapped and characterized using a combination of bioorganic and biophysical methods. Several lines of evidence indicate that IspH exists as protein complexes. In Aim 2, by making use of the strains, reagents, and reporter systems obtained in the preliminary studies, several complementary approaches will be utilized to identify IspH partner proteins and study their functions.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed isoprenoid biosynthetic studies will guide the development of mechanism- based inhibitors of the DXP pathway enzymes, which can be used as broad-spectrum antibiotics. The public health benefit will result from the development of effective new treatments for drug-resistant strains of pathogens, currently of increasing concern worldwide. NARRATIVE The proposed isoprenoid biosynthetic studies will guide the development of mechanism- based inhibitors of the DXP pathway enzymes, which can be used as broad-spectrum antibiotics. The public health benefit will result from the development of effective new treatments for drug-resistant strains of pathogens, currently of increasing concern worldwide. __SpecificAimsTextDelimiter__ 2.0 SPECIFIC AIMS Representing 25 - 30% of known natural products, isoprenoids are the most diverse group of metabolites in both structure and function.8 All isoprenoids are constructed from two precursors, isopentenyl diphosphate (IPP, 9, Fig. 1) and its isomer dimethylallyl diphosphate (DMAPP, 10, Fig. 1).9,10 There are two different pathways for IPP and DMAPP biosyntheses:(1) the DXP pathway (Fig. 1) in green algae, the chloroplasts of higher plants, and most eubacteria; (2) the mevalonic acid (MVA) pathway in animals, fungi, and archaebacteria.20 Due to the well-defined distribution of the two pathways among different kingdoms, the DXP pathway enzymes are ideal candidates for developing broad-spectrum antibiotics.22 The DXP pathway is also targeted for herbicide development because its plant mutants are not able to synthesize sufficient amounts of carotenoids and chlorophylls for normal growth.23 Many isoprenoids have commercial value.24 Because of their low natural abundance, there is a growing interest in producing them through bioengineering,25-28 e.g., the production of anti-malaria drug artemisinin (funded by the Bill & Melinda Gates Foundation at Amyris biotechnologies Inc). The limiting factor in bioengineering-based isoprenoid production is the inadequate supply of IPP and DMAPP.30 The mechanistic studies of enzymes in isoprenoid biosynthesis proposed here will have significant impact in guiding the development of the DXP pathway enzyme mechanism-based inhibitors as antibiotics and in constructing host strains for bioengineering-based isoprenoid production. The successful preliminary studies in our laboratory have developed all the materials and protocols for the proposed work. In these studies, we have achieved a 97-fold activity improvement in one of the rate-limiting steps in IPP and DMAPP biosynthesis, the IspH-catalyzed reaction (red portion, Fig. 1).31 In addition, using substrate analogs, we have examined several IspH mechanistic models in the literature and narrowed them down to a model that is consistent with all current data.12,31-33 We have also successfully incorporated [57Fe] into IspH and isolated [57-Fe]-labeled IspH in large quantities (~ 500 mg from a one-day purification).31 EPR and Mössbauer characterizations of isolated IspH indicated that using our purification method, no iron-sulfur reconstitution is needed and the isolated protein has close to one [4Fe-4S] cluster per IspH monomer. Also, nearly 90% of the cluster is the desired [4Fe-4S]2+ and the rest 10% is [3Fe-4S]+, which can be converted to the desired [4Fe-4S]2+. Results from these preliminary studies addressed all of the scientific concerns from the reviewers of the previous submission. O 1 CO2- CO2 OH NADPH NADP+ HO O DXS IspC OH (DXR) OH OH H OPi 3 4 OH 2 (DXP) CTP IspD (YgbP) PPi O OPi OPi PiO ADP ATP HO IspE OH OH (YchB) OH OH OCDP OCDP CMP 6 5 IspF (GgbB) OO- O P OPO O- O IspG OH OH (GcpE) 7 OPPi 9 (IPP) OPPi IspH OH (LytB) 8 OPPi 10 (DMAPP) Fig. 1. DXP pathway and enzymes. Through an innovative combination of bioorganic, biophysical, and molecular biology approaches, we will characterize both enzyme- and substrate-based intermediates in IspH-catalyzed reductive dehydration reactions (red portion, Fig. 1). In addition, IspH activity is regulated 20 or IspH is used to regulate other processes17 (e.g., the cellular stringent responses 6) by forming protein complexes. Several complementary approaches will be utilized to identify IspH partner proteins and study their functions. Specifically, in the proposed work, we will: Aim 1. Characterize the IspH reaction intermediates. Based on our preliminary studies, by a combination of IspH enzyme mutants, IspH substrate analogs, and isotopically labeled mechanistic probes, we will trap both enzyme- and substrate-based intermediates using rapid freeze-quench and characterize them by biophysical methods (e.g., EPR and Mössbauer spectroscopies, and electrochemistry). Aim 2. Identify IspH partner proteins. Several lines of evidence indicate that IspH exists as protein complexes. In this specific aim, by making use of the strains, reagents, and reporter systems obtained in our preliminary studies, several complementary approaches (e.g., reporter-system based screenings, immuno- precipitation, genome-wide two-hybrid based screening, and affinity chromatography) will be utilized to identify IspH partner proteins and study their functions.